Structure and Function of TRPV channels

Title: Structure and Function of TRPV channels
The long-term objective of this research program is to understand the molecular mechanisms of gating and
cellular function of the two physiologically important members of the TRPV subfamily: transient receptor potential
vanilloid 2 (TRPV2) and transient receptor potential vanilloid 5 (TRPV5). These channels belong to the same
subfamily of TRP channels, nevertheless they exhibit striking differences in their tissue distribution, physiological
function, cellular localization, ion permeation and selectivity, mechanisms of channel gating and pharmacology.
TRPV2 is broadly expressed Ca2+-permeable non-selective cation channel, which plays a vital role in neuronal
development, immunity, cardiovascular physiology, and cancer. TRPV5 is a highly selective Ca2+ channel, that
is only expressed on the apical membrane of kidney distal convoluted tubule epithelial cells and plays a critical
role in Ca2+ homeostasis in the human body. This proposal is built on the major advances achieved by my group
in understanding TRPV2 and TRPV5 channels structures, molecular details of gating and cellular function in the
last 10 years. The overall goal of this proposal is to further understand how TRPV2 and TRPV5 channels are
gated by endogenous and exogenous modulators at the atomic level; and to elucidate TRPV2 channel precise
molecular function in neuronal development and immunity. To answer these questions, we will employ cutting-
edge multidisciplinary approaches available to our laboratory, including membrane protein biochemistry and
biophysics, single-particle cryo-EM, peroxidase-catalyzed proximity labeling and mass spectrometry, cryoAPEX
for electron microscopy imaging, flow cytometry, confocal fluorescence microscopy, and functional
characterization by electrophysiological and cell biological methods. This information would be critical in our
understanding of TRPV channels physiological and pathophysiological roles.

Public health relevance
PROJECT NARRATIVE The transient receptor potential vanilloid channels, TRPV2 and TRPV5, contribute to a broad range of physiological and pathophysiological events in human body. The overall goal of this proposal is to understand how TRPV2 and TRPV5 channels are gated by endogenous and exogenous modulators at the atomic level; and to elucidate TRPV2 channel precise molecular function in developing neurons and immune cells.